A Family-Based Alcohol Preventive Intervention for Latino Emerging Adults

? DESCRIPTION (provided by applicant): In the proposed study, we will develop and pilot-test a family-based underage drinking prevention program for Latino emerging adults. The program will include a parenting component, to be delivered to the parents of the emerging adult, and an identity development component, to be delivered to the emerging adult her/himself. The project will be divided into three phases: (1) development of the intervention components (including writing first drafts of the intervention manuals); (2) initial pilot testing and focus group feedbak (including modifying the intervention and revising the manuals); and (3) a randomized pilot study. All three steps will be carried out in both Miami-Dade County, Florida, and Lane County, Oregon. The parenting component will be developed by adapting efficacious parenting strategies used with adolescents so that the activities are developmentally appropriate for parents of emerging adults. The identity development component will be developed by integrating identity-based intervention strategies that have been used successfully with adolescents and emerging adults, again ensuring that they are developmentally appropriate. Developing, refining, and pilot testing the intervention across two very different contexts (urban versus rural) and Latino subgroups (primarily Cuban, Nicaraguan, and Colombian in Florida versus primarily Mexican in Oregon) will permit us to examine the extent to which our proposed intervention has the potential to be efficacious across a range of contexts and Latino subgroups.

Public health relevance
PUBLIC HEALTH RELEVANCE Underage drinking is a major public health problem, resulting in costs to society of nearly $25 billion per year in emergency room visits, sexually transmitted infections, treatment of serious injuries, and years of life lost, among other costs. Compared to their White counterparts, Latino youth are more likely to be killed in drunk driving crashes, to be arrested for (or victimized in) violent acts while drunk, and to engage in unprotected sexual activity after drinking. These behaviors tend to be especially severe between ages 18 and 20. Our proposed study will help to address these disparities in alcohol-related consequences by developing and pilot testing a family-based intervention for Latino emerging adults ages 18-20. This intervention will capitalize on the tendency for Latino emerging adults to live at home with their families. Supportive family processes such as involvement, cohesion, and communication will be promoted in group sessions with parents, and an identity development component will be created to help emerging adults deal with the tasks of deciding on a life path, reconciling different roles and expectations (e.g., gender roles) within Latino and U.S. cultural contexts, and deciding what it means to be a Latino person in the United States. The activities within the family-based and identity-based components will be drawn and modified from efficacious intervention work with Latino adolescents and from existing identity development interventions for emerging adults.